Cryo-Electron Tomography derived cell population analysis through novel high-throughput machine learning approaches

Project Summary
Cryo-electron tomography (Cryo-ET) has emerged as a major tool for in situ biology which enabled the system-
atic 3D visualization of subcellular objects and their spatial organization. Cryo-ET enables recovering entire
subcellular morphologies and organizations across different cell populations, bringing signiﬁcant potential for
downstream biomedical tasks of phenotype-genotype analysis, disease diagnosis, and drug design. A major
challenge in utilizing the potential of Cryo-ET for such downstream tasks is the lack of methods to systematically
study the cell-population-wide differences in subcellular object morphology and their spatial organization. The
goal of this program is to develop novel high-throughput machine-learning approaches to study cell-population-
wide differences in subcellular object morphology, conformations, and organization. We set out to solve multiple
computational problems toward this goal. The current deep learning-based cellular cryo-ET tomogram analysis
approaches have limited data-efﬁciency and apply to one or a few tomograms having similar data domains.
Consequently, they are unsuitable for large-scale analysis of tomograms of diverse data domains that can be
used to image a cell population. In our ﬁrst module, we will develop domain generalization methods to im-
prove the data efﬁciency of existing deep learning-based cryo-ET image analysis methods. Our next module
will develop high-throughput methods for coarse-to-ﬁne segmentation of multi-scale subcellular objects in cryo-
ET tomograms with unsupervised and weakly-supervised learning. In the following module, we will develop
novel representation learning methods for statistical shape and morphology analysis of the subcellular objects.
Finally, we will develop interpretable methods to study cell population-wide shape and spatial traits of multi-
scale subcellular objects with multiple biological co-variates. In addition to the novel algorithms, we will create
user-friendly software with a Graphical User Interface (GUI) incorporating the algorithms that will ensure the
biologists can leverage cryo-ET for cell-population analysis.

Public health relevance
Project Narrative This program will create a series of data-efﬁcient machine-learning algorithms to facilitate cellular cryo-ET- derived cell population-wide analysis of subcellular objects. For easy use, we will develop an open-source software with GUI to pipeline the new approaches from the subcellular object segmentation step to the ﬁ- nal cell population-wide analysis of the structure and morphology of subcellular objects. We will validate the performance of our system by applying it to publicly available large-scale Cryo-ET datasets and monitor the improvement of the ﬁnal results.